Role of physical exercise-induced microbiota changes in immunotherapy resistant preclinical melanoma

PROJECT SUMMARY/ABSTRACT:
Physical inactivity is a leading risk factor for development of non-communicable diseases, including cancers.
Increased exercise has been shown to benefit cancer patients by improving response to immune checkpoint
inhibitor (ICI) treatments. Preclinical models suggest exercise facilitates these benefits by modulating antitumor
immune responses, including changes to CD8 T cell tumor infiltration and effector function. However,
mechanisms by which exercise induces these immunologic changes remain poorly understood. Exercise is
known to change the composition and function of the gut microbiota. Many researchers, including our lab, have
demonstrated that gut microbiota composition dictates efficacy of ICI therapy in melanoma. Thus, in our work,
we seek to uncover whether and if so how exercise-induced changes to the microbiota impact on tumor immunity
and ICI efficacy, a concept which has never been tested before. In key preliminary data we show that treadmill
running exercise restrains YUMM1.7 melanoma tumor growth, prolongs survival, and sensitizes this ICI-resistant
model to αPD-1 therapy. Exercise-driven tumor suppression requires adaptive immunity, specifically CD8 T cells,
and exercise promotes enhanced antitumor effector cytokine production in CD8 T cells (including interferon-
gamma producing Tc1 cells). Excitingly, we find that our exercise regimen induces compositional changes to the
gut microbiota, and that the microbiota is required for exercise tumor suppression. We further show that fecal
microbiota transplantation (FMT) of the exercised microbiota (ex-microbiota) is sufficient to enhance systemic
Tc1 immunity and confer tumor suppression in sedentary mice; but only when the ex-microbiota is metabolically
active, suggesting that microbial metabolites produced by the ex-microbiota play a key role. Preliminary tumor
homogenate cultures indicate an expansion of three bacterial species within tumors of exercised mice, begging
the question whether exercise-induced compositional changes to the tumor microbiota contribute to
immunomodulatory effects of exercise. Our central hypothesis is that physical exercise induced microbiota
changes promote anticancer Tc1 cell immunity and therefore sensitize ICI-resistant melanoma to ICI
therapy. In this proposal, we will assess if and how ex microbiota metabolites (i) act directly upon CD8 T cells
to promote antitumor function, (ii) improve tumor antigen specific CD8 T cell immunity, and (iii) improve sensitivity
to ICI therapy (Aim 1). Further, we will evaluate the requirement and sufficiency of the intratumoral microbiome
for exercise-mediated tumor suppression and ICI sensitization in our model (Aim 2). Successful completion of
this study will identify novel mechanisms by which the exercised-microbiota impacts on CD8 T cell immunity and
elucidate microbial therapeutic targets that can be used to reproduce key immunomodulatory benefits of exercise
for cancer patients.

Public health relevance
PROJECT NARRATIVE: Exercise is known to benefit cancer patients by promoting their response to immunotherapies, but the mechanisms of how exercise does this remain elusive. In this study, we will identify mechanisms of how exercise promotes improved anticancer immune cell activation and immunotherapy efficacy through changes to the commensal bacteria which colonize the gut and tumor. Completion of this study will identify novel bacterial species and/or bacterial products which can be used to reproduce key benefits of exercise for cancer patients.